An intelligent clinical decision support system for peripheral arterial disease

PROJECT SUMMARY / ABSTRACT
Unstructured clinician notes contain “80% of medical information” in the electronic health record (EHR) but
are cumbersome to search and analyze. Multiple national thought leaders in health care, including the National
Academy of Science, Engineering and Medicine have called for improved “access, tools, and capacity for
[clinical] data analysis.” Yet, our inability to search, summarize, and extract knowledge from clinical notes
remains a major technical impediment to replace the tedious, time-consuming task of human chart review.
Large language models (LLMS) are advanced deep learning algorithms capable of the understanding of
concepts and context from text. They facilitate several tasks relevant to digital chart review such as advanced
information search and retrieval. Furthermore, LLMs can generate coherent prose to form context specific
summarizations. Together, these two abilities hold the potential of realizing the vision of a world where most
clinical decisions are cost-effectively “supported by accurate, timely, and up-to-date clinical information.”
Nevertheless, real world deployment of digital chart review must ensure performance (i.e. accuracy, reliability)
and clinicians’ compatibility to facilitate effective and sustainable interactions with clinicians within the context of
their clinical workflows.
Our research goal is to develop a digital chart review for providing clinicians with accurate and actionable
information at the point of care. Our central hypothesis is that a domain adapted LLMs can deliver a decision
focused chart summary which is comparable to human chart review by vascular surgeons. We will test this
hypothesis using real world data from a large statewide health information exchange on more than 124,000
patients with peripheral arterial disease i.e. PAD (the leading cause of amputation in the US). The mentorship
panel developed a set of research activities to execute the following aims that are aligned with the candidate’s
overall goal of becoming an independent clinical investigator capable of using advances in health information
technology to transform vascular care, and thus the health outcomes of underserved communities living with
PAD.
In Aim 1 we design and validate a large Language Model capable of extracting and summarizing PAD
information from plain text notes. We will evaluate the outputs of the large Language model for accuracy,
completeness, relevance, and uncertainty using industry standard metrics. We hypothesize that the LLM text
extraction and summarization is comparable to human chart review. In Aim 2, we Co-design with clinicians a
minimally viable prototype of a digital chart review system. We will incorporate feedback from the clinicians using
the iterative Agile Innovation process. We hypothesize that different clinical scenarios will require emphasis of
different information types.

Public health relevance
PROJECT NARRATIVE Peripheral arterial disease (PAD) is the leading cause of non-traumatic amputation and impacts 8.5 to 12 million Americans. Our work will develop and validate a deep learning-based system for extracting and summarizing PAD-specific information form electronic health records. This project will enable future studies seeking to better optimize PAD care by allowing for accurate, reliable, and scalable digital chart review.